Tumor and Immune Cell Dynamics during Immunotherapy and Cancer Progression

PROJECT SUMMARY
Treatment of cancer has been transformed by immunotherapies that aim to reactivate tumor-specific immune
cell responses, in particular checkpoint blockade therapies that target inhibitory receptors on T cells. Although
these therapeutics have achieved durable clinical responses, many patients do not respond or shortly relapse.
Rationale design of effective immunotherapy strategies requires a detailed understanding of the dynamics
between tumors and the immune system. My goal is to decode these dynamic interactions using a combination
of in vivo models, genomic technologies, and large-scale analyses of patient data to gain novel insights into the
biological processes that underlie cancer progression and response to immunotherapy. In the F99 phase, I aim
to identify to origin of immune cells that respond to checkpoint blockade. An outstanding question is whether the
T cell response to checkpoint blockade relies on reinvigoration of pre-existing tumor-infiltrating lymphocytes or
on recruitment of novel T cells. In my dissertation work so far, I have used single cell RNA and T cell receptor
(TCR) sequencing of site-matched tumor biopsies before and after PD-1 blockade to profile clonal T cell
dynamics in response to immunotherapy. I found that T cells that clonally expand in response to PD-1 blockade
are enriched for novel clones that have not been previously observed in the same tumor, a phenomenon we
term clonal replacement. However, the source of novel T cells as well as the role of other immune cell populations
in this process remain unclear. I hypothesize that novel T cells are derived from secondary lymphoid organs and
that overcoming deficiencies in T cell priming by antigen presenting cells is required for clonal replacement
following PD-1 blockade. I will use a combination of flow cytometry, single cell sequencing, and bulk TCR
sequencing of in vivo syngeneic mouse tumor models to determine the origin of T cells that respond to PD-1 and
CTLA-4 blockade. Further, I will use genetic mouse models to determine the role of PD-L1 expression on antigen
presenting cells, in particular conventional type 1 dendritic cells, on PD-1 blockade efficiency. In the K00 phase,
I aim to elucidate the relationship between extrachromosomal DNA amplification, innate immune signaling, and
the efficacy of checkpoint blockade. Copy number alterations leading to oncogene amplification frequently occurs
on circular extrachromosomal DNA (ecDNA), which are commonly found in the cytoplasm due to lack to
centromeres and associate with loss of cytosolic DNA sensing through the cGAS-STING pathway. Further,
innate immune signaling through cGAS-STING has been shown to improve the efficacy of checkpoint blockade.
I propose that loss of cytosolic DNA sensing is permissive for extrachromosomal DNA production, which
promotes tumor progression not only through oncogene amplification but also through impaired innate immune
signaling, limiting immune surveillance and the efficacy of checkpoint blockade. Together, this work will provide
novel insights into immune and tumor dynamics that underlie cancer progression and response to
immunotherapy.

Public health relevance
PROJECT NARRATIVE Improving and maintaining durable clinical responses to cancer immunotherapy requires a detailed understanding of dynamics between tumor and immune cells, particularly in the context of checkpoint blockade. I propose to elucidate the origin of immune cells that respond to checkpoint blockade as well as how genetic alterations in tumor cells affect immune surveillance in the context of immunotherapy. This work will provide novel insights into cellular mechanisms that underlie response to immunotherapy to help inform rational therapeutic strategies.